CK20-004, WASHINGTON UNIVERSITY & BJC EPICENTER TO PREVENT HEALTHCARE ASSOCIATED INFECTIONS & ANTIBIOTIC RESISTANCE

ABSTRACT
The Washington University (WU) / BJC Prevention Epicenter (PE) works collaboratively with CDC & other
PEs to perform research & translate discoveries into novel strategies to prevent healthcare-associated
infections (HAI) & antimicrobial resistance (AR). The WU/BJC PE is widely recognized for HAI & AR research
& leadership. WU has outstanding research infrastructure. BJC is an integrated healthcare delivery system
with 15 hospitals, long-term care facilities, & outpatient practices. BJC includes two academic hospitals,
Barnes-Jewish & St. Louis Children’s Hospitals & 13 suburban & rural hospitals. We organized a research
team with expertise in ID, epidemiology, informatics, microbiology, critical care, microbiome, & metabolism to
study HAI & AR in diverse settings. We developed a high impact 5-yr proposal with novel strategies to:
Evaluate & predict inappropriate antimicrobial use & AR regionally & nationally; Reduce surgical site infections;
Test novel initiatives to improve outpatient antibiotic prescribing; Identify metagenomic & metabolite differences
between hospital & community associated C. difficile; Reduce AR organism reservoirs in hospitals.
To achieve these goals, we propose the following Specific Aims:
Aim 1 A: Evaluate the use, effectiveness, and safety of antimicrobials in community-acquired pneumonia
(CAP) with national administrative data.
Aim 1 B: Develop aggregate antimicrobial resistance measures in sepsis caused by Gram-negative bacilli
(GNB) using BJC electronic health record data.
Aim 2: The impact of an existing Anesthesia Control Tower (ACT) intervention to improve intraoperative
care on infectious outcomes.
Aim 3 A: Stewardship initiative to limit post-discharge prophylactic antibiotic use after mastectomy.
Aim 3 B: Improve antimicrobial stewardship practices in elderly patients with UTIs in assisted living
facilities.
Aim 4: Identify fecal microbiome and metabolite markers of community associated (CA) C. difficile
colonization and infection (CDI).
Aim 5: Define the prevalence of antibiotic resistant organisms (ARO) in the clinical ICU environment,
relationship of ARO to ICU clinical culture isolates and measure the impact of an environmental hygiene
intervention on ARO concentration in ICU sink drains, the surrounding environment and bioaerosols.
We are also submitting 3 proposals to lead Small, Medium & Large Multicenter Collaborative Projects with
Duke, U Penn, Hektoen / Rush, University of Maryland, and Iowa PEs as potential participants.

Public health relevance
PROJECT NARRATIVE The Washington University/ BJC Prevention Epicenter performs research to prevent healthcare associated infections and antibiotic resistance in healthcare settings and the community. We do studies with large administrative data, electronic health records, patients and biospecimens. We develop and test Interventions to improve antibiotic use, & disinfection methods, & identify new biomarkers to reduce antibiotic resistance, infections and improve public health.